Alzheimer's Disease and Related Dementia-like Sequelae of SARS-CoV-2 Infection: Virus-Host Interactome, Neuropathobiology, and Drug Repurposing

PROJECT SUMMARY
Abundant cross-interdisciplinary evidence indicates that there are multiple pathophysiological processes driving
development and progression of Alzheimer’s disease (AD) and AD-related dementias (ADRD), including
neuroinflammation and microvascular injury to pathogens, especially viruses. We are examining these aspects
of AD/ADRD with respect to human coronavirus disease 2019 (COVID-19), which is caused by the severe acute
respiratory syndrome coronavirus 2 (SARS-CoV-2) with over 87 million cases in the United States alone. Notably,
substantial evidence indicates neurocognitive sequelae of COVID-19, which are poised to ultimately lead to a
surge in cases of AD/ADRD, and other forms of neurocognitive impairment. Preliminary evidence from our team
identified that SARS-CoV-2 infection caused neuroinflammation and brain microvascular injury, two major
risk factors for AD/ADRD. We have also demonstrated that systematic characterization of human- and virus-
human protein interactome maps can identify novel pathophysiological pathways and drug targets to protect
the SARS-CoV-2-infected brains. We therefore posit that multimodal analyses of SARS-CoV-2-human
interactome maps in patient induced pluripotent stem cell (iPSC)-derived brain microvascular endothelial
cells (BMECs) and brain single-nucleus genomic/epigenomic data from de novo AD/ADRD-like neurocognitive
impairment in COVID-19 patients (Neurocogn-COVID), will provide valuable unbiased insights into the complex
etiology of neurocognitive sequelae of SARS-CoV-2 at molecular, cellular and network levels. This project will
elucidate critical understanding of both brain cell type-specific virus-human protein interactome-inhibitory targets
and neuro-immune gene networks and brain microvascular injury that may lead to AD/ADRD after viral infection.
Our immediate goal is to build a comprehensive, brain cell type-specific virus-human protein interactome map
for identifying molecular drivers for neurocognitive sequelae of SARS-CoV-2 infection using our high-throughput
protein interactomics platform. Aim 1 will interrogate the SARS-CoV-2 virus-human interactome to identify and
validate molecular drivers of ADRD-like viral microvascular injury in iPSC-derived BMECs (age-, sex-, APOE-
matched iPSC lines). Aim 2 will interrogate cell type-specific neuroimmune and brain endothelial transcriptional
networks to identify pathophysiology related to virus-induced neuro-inflammation and brain microvascular injury.
We will leverage single-nucleus genomic/epigenomic data generated from brain tissues of donors who suffered
from neurocogn-COVID, AD, mild cognitive impairment (MCI), and age-, sex-, APOE-matched healthy controls
from the Cleveland Alzheimer's Disease Research Center (ADRC) and Northwestern ADRC. Aim 3 will test the
hypothesis that potential new opportunities for drug repurposing in neurocognitive sequelae can be identified
through a combination of longitudinal population-based validation and functional testing in mouse models.
Successful completion of this project will elucidate mechanistic biomarker for neurocognitive sequelae of SARS-
CoV-2 and identify new drug targets and treatments to be directly tested in clinical trials.
1

Public health relevance
Project Narrative Alzheimer’s disease (AD) is a devastating neurodegenerative disease that is estimated to affect 16 million Americans and 90 million people worldwide by 2050, and this problem is projected to grow even more with the compound effect of the COVID-19 pandemic, which is linked to neurocognitive sequelae of SARS-CoV-2 infection. We will build the first brain cell type-specific SARS-CoV-2 virus-human protein interactome map in human induced pluripotent stem cell (iPSC)-derived brain microvascular endothelial cells (BMECs) and identify cell type-specific neuro-immune gene transcriptional signatures and networks underlying neurocognitive sequelae of SARS-CoV-2 infection. The brain cell type-specific comprehensive SARS-CoV-2 virus-host interactome map will be applied to identify novel drug targets and effective treatments for AD, which will be validated through a combination of large-scale, longitudinal patient data and functional test in AD transgenic mouse models. 1